Evaluation of novel markers of exposure and biological response to 1,4-dioxane

Project Summary/Abstract
1,4-Dioxane (1,4-DX) is a synthetic chemical historically used as a stabilizer of chlorinated solvents and
currently used in a range of consumer and personal care products. Over one-fifth of the US public drinking
water supply contains detectable levels of 1,4-DX, and approximately 7% of drinking water samples tested
exceed the federal cancer risk level of 0.35 μg/L. Widespread contamination of drinking water has been
observed in groundwater in Nassau and Suffolk Counties of Long Island, New York, where 75% of population
have water sources with 1,4-DX concentrations exceeding 0.35 μg/L. Furthermore, standard municipal
treatment systems are ineffective at removing 1,4-DX, enabling its persistence in drinking water supplies. The
US Environmental Protection Agency (EPA) has designated 1,4-DX as a “high priority” chemical and classified
it as a probable human carcinogen based on evidence from experimental animal studies, primarily based on
effects on the liver. Despite the high prevalence in the environment and potential human health risks, there is a
paucity of human exposure and health data. We will apply novel approaches to evaluate exposure to 1,4-DX
and co-occurring contaminants (such as the volatile organic compounds 1,1-dichloroethane (DCA),
trichloroethylene (TCE), and 1,1,1-trichloroethane (TCA)) in two communities: Long Island, New York (our
primary study area) and Cape Fear River Watershed, North Carolina (secondary study area). We will use our
newly developed, highly sensitive mass spectrometry-based assay for assessment of exposure to 1,4-DX in
water and blood samples. In addition, we will evaluate associations between exposure to 1,4-DX and co-
contaminants and levels of endogenous metabolites and lipids in blood using both untargeted and targeted
metabolomics. The use of biomonitoring and metabolomics provide powerful tools to assess early exposures
and biological changes in the years preceding clinical manifestation of disease. We propose a cross-sectional
study on Long Island (an area with many Superfund sites potentially contributing to contamination of drinking
water with 1,4-DX) to i) assess human exposure to 1,4-DX and evaluate the relationship between
environmental and biological exposure indicators, ii) evaluate temporal variability of exposure to 1,4-DX and
metabolite levels by comparing data from two different US regions with different water sources (ground water
in NY and surface water in NC), and iii) evaluate the relationship between 1,4-DX exposure and metabolites of
biological responses particularly for liver toxicity and carcinogenesis. This project will greatly enhance our
understanding of the extent of exposure to 1,4-DX (and its co-occurring contaminants) in drinking water and
the potential for human health effects. The results will provide scientific evidence for policy makers to set
guidelines for concentration standards for 1,4-DX and provide researchers in the Superfund Research Program
with new tools to detect hazardous substances in the environment as well as novel technologies for
remediation.

Public health relevance
Project Narrative The industrial chemical 1,4-dioxane has been identified as a drinking water contaminant throughout the United States and has been classified as a probable human carcinogen based on evidence from experimental animal studies. Human exposure and health impacts of 1,4-dioxane remain poorly understood in part because traditional techniques cannot detect low-level concentrations of 1,4-dioxane in biological samples or drinking water samples. To address the goals of the Superfund Research Program, our study will use a more sensitive approach to measure human exposure to 1,4-DX and its co-occurring contaminants, and assess links to early biological effects to determine the potential health impact for residents of Long Island, New York, an area with many Superfund sites potentially affected by 1,4-DX.